Gene Specific Regulation of NFkB by Nuclear IkBa in Inflammation and Cancer

DESCRIPTION (provided by applicant): Our long-term goal is to understand the mechanisms regulating transcription of NFκB-dependent anti-apoptotic and pro-inflammatory genes. Since NFκB activity and expression of NFκB-regulated pro-inflammatory and anti-apoptotic genes are increased in many inflammatory diseases, as well as in many types of human cancer and leukemia, inhibition of NFκB-dependent transcription thus represents an important therapeutic target. However, one of the main concerns regarding the NFκB inhibitors is their specificity, since many steps leading to NFκB activation are important for other cellular functions as well. Our previous studies have shown that an induction of nuclear translocation and accumulation of the NFκB inhibitor, IκBα, inhibits the in vitro NFκB DNA binding activity and induces apoptosis in human leukocytes and cancer cells. Importantly, our recent data indicate that the in vivo inhibition of NFκB-dependent transcription by nuclear IκBα is gene specific: while the transcription of pro-inflammatory cytokines TNFα, IL-12 and IL-6 in human leukocytes is inhibited by nuclear IκBα, transcription of IL-8 is not. However, at present, the mechanisms that regulate the in vivo nuclear interaction of IκBα with NFκB proteins and NFκB- dependent promoters are unknown. The central hypothesis of this proposal is that the regulation of NFκB-dependent transcription of pro-inflammatory and anti-apoptotic genes by nuclear IκBα is gene specific, and could thus provide a basis for novel anti-inflammatory and anti-cancer therapies aimed at the specific inhibition of NFκB activity by nuclear IκBα. The specific aims focus on analyzing the mechanisms that regulate the in vivo binding of IκBα to NFκB dimers and NFκB promoters, thus regulating NFκB-dependent transcription. In Aim 1, we will measure by chromatin immunoprecipitation the recruitment of NFκB and IκBα proteins to NFκB-regulated promoters of pro-inflammatory and anti-apoptotic genes in human U937 macrophages and leukemia Hut-78 cells. We will determine whether the ability of nuclear IκBα to inhibit NFκB-dependent transcription depends on the subunit composition of NFκB dimers. In Aim 2, we will identify the mechanisms that regulate the nuclear IκBα-NFκB interaction in U937 macrophages and Hut-78 leukemia cells, and we will test the hypothesis that the responsible mechanisms involve post-translational modification(s) of p65 NFκB, and/or gene specific recruitment of the proteasome. Identification of the mechanisms that regulate the gene specific transcription of NFκB-dependent genes by nuclear IκBα might provide a new strategy that would use the nuclear IκBα as a specific regulator of NFκB-dependent transcription. This approach could be applicable in both anti-inflammatory and anti-cancer therapies. In addition, this project will enhance the research environment at St. John's University by providing undergraduate students with numerous opportunities to learn the fundamentals of biomedical research. PUBLIC HEALTH RELEVANCE: This proposal focuses on the mechanisms that regulate ability of the nuclear inhibitory protein IκBα to associate with NFκB-regulated promoters and inhibit transcription of NFκB-dependent inflammatory and pro-survival genes. Since NFκB activity is increased in many human diseases including inflammatory disorders, cancer, and leukemia, identification of the mechanisms by which the nuclear IκBα inhibits NFκB-dependent transcription will lead to the development of more specific anti-inflammatory and anti-cancer therapies.

Public health relevance
PROJECT NARRATIVE This proposal focuses on the mechanisms that regulate ability of the nuclear inhibitory protein IκBα to associate with NFκB-regulated promoters and inhibit transcription of NFκB-dependent inflammatory and pro-survival genes. Since NFκB activity is increased in many human diseases including inflammatory disorders, cancer, and leukemia, identification of the mechanisms by which the nuclear IκBα inhibits NFκB-dependent transcription will lead to the development of more specific anti- inflammatory and anti-cancer therapies.